Molecular Pathogenesis and Therapy of Systemic Histiocytic Neoplasms

Project Summary
Histiocytic neoplasms are clonal disorders of the monocyte/macrophage lineage that include Langerhans Cell
Histiocytosis (LCH), Erdheim-Chester Disease (ECD), Juvenile Xanthogranuloma (JXG), and Rosai-Dorfman
Disease (RDD). Although the pathogenesis of histiocytoses was previously obscure, it is now known that
nearly every patient with these disorders has a mutation activating MAP kinase (MAPK) signaling, including
BRAFV600E mutations in 50% of LCH and ECD cases. BRAF inhibition is efficacious for those patients with
BRAFV600E-mutant disease and our clinical trial led to FDA approval of vemurafenib for BRAFV600E-mutant ECD
in 2017. Correlative analyses from this study revealed that the allelic burden of mutant cell-free DNA in the
plasma is a dynamic and reliable biomarker of therapeutic response in BRAFV600E-mutant histiocytosis. Prelim-
inary data: More recently, a wide spectrum of genomic alterations in kinase signalling components were iden-
tified in BRAFV600E-wildtype (WT) histiocytic neoplasms. Diverse mutations in MEK1/2 and ARAF are among
the most common, accounting for >50% of BRAFV600 WT cases. Patients with BRAFV600-WT histiocytosis have
also been treated with MEK inhibition, both within a phase 2 clinical trial (NCT02649972) and in clinical prac-
tice. Knowledge gap: In contrast to the near-universal activity of BRAF inhibition for BRAFV600E-mutant histio-
cytosis, patients with BRAFV600-WT histiocytosis exhibit heterogeneity in their responses to MEK inhibition, the
basis of which remains unknown. Moreoever, many alterations in components of the MAPK pathway in histio-
cytoses have not been functionally characterized. The hypothesis of this study is that tumor cell-intrinsic ge-
netic alterations correlate with response to MEK inhibition in histiocytosis. This hypothesis will be tested by
evaluating therapeutic responses to MEK inhibition in our cohort of BRAFV600-WT histiocytosis patients with
diverse MAPK pathway mutations, and with innovative genomic analysis of plasma cell-free DNA to identify
biomarkers of response. Memorial Sloan Kettering Cancer Center is the leading referral center in the U.S. for
adults with histiocytosis—making it ideally suited to conduct this work. In parallel, the mechanistic and thera-
peutic implications of mutations in MEK1/2 and ARAF (which represent the most commonly mutated genes in
BRAFV600-WT patients) will be investigated. Although ARAF and MEK1/2 mutations are recurrent across many
cancers, the unique enrichment of these mutations in histiocytoses provides an opportunity to functionally dis-
sect mechanisms by which ARAF and MEK1/2 regulate MAPK signalling and drive cancer. Impact: This pro-
ject will improve our understanding of histiocytosis pathogenesis, mechanisms of MAPK pathway activation,
and determinants of response to MEK inhibition. Aim 1: Characterize the clinical and molecular response of
histiocytosis to MEK inhibition in a prospectively treated patient cohort, including an ongoing phase 2 clinical
trial. Aim 2. Understand the biochemical impact and therapeutic implications of MEK1/2 and ARAF mutations
in patients with histiocytoses.

Public health relevance
Project Narrative This study will test the hypothesis that tumor cell-intrinsic genetic alterations correlate with response to MEK inhibition in systemic histiocytocytic neoplasms. Although ARAF and MEK1/2 mutations are recurrent across many cancers, the enrichment of these mutations in histiocytoses provides a unique opportunity to functionally dissect mechanisms by which ARAF and MEK1/2 regulate MAPK signaling and drive cancer. The results from this study will improve our understanding of histiocytosis pathogenesis, mechanisms of MAPK pathway activation in cancer, and determinants of response to MEK inhibition.